Super-resolution mobile microscopy

Abstract:
Mobile microscopy, with its portability and multimodal capabilities, holds immense significance across
healthcare, environmental monitoring, and research. It equips healthcare providers to deliver rapid diagnostics
in remote areas, detecting conditions like sickle cell disease, cervical cancer, and pathogens. In environmental
monitoring, it aids in on-site analysis of water quality, air pollutants, and pathogens, bolstering environmental
safety. Researchers benefit from its field-ready flexibility, contributing to advancements across disciplines.
Moreover, it's becoming a key tool in education. By bridging geographical and resource gaps, mobile
microscopy makes critical information and analysis tools accessible where needed most, offering invaluable
insights. However, mobile microscopy grapples with resolution limitations due to its compact optics, hindering
its applicability in high-resolution imaging. To address this, we propose a universal imaging technique based
on point spread function (PSF) modulation. By introducing a modulator that produces higher spatial
frequencies in the PSF, super-resolution imaging becomes achievable, impacting mobile microscopy across
various platforms, including smartphones, and extending to holography and traditional laboratory microscopes.
This project marks a transformative step toward accessible high-resolution imaging beyond the laboratory.

Public health relevance
NARRATIVE Although mobile microscopy holds significant importance in various fields, including healthcare, environmental monitoring, and research, due to its portability and accessibility and multimodality, which can provide a magnitude of information, its image resolution is poorer than conventional bright-field bench-top laboratory microscopes. The proposed project is to apply a new simple, but universal super-resolution imaging technique to mobile microscopes to increase their spatial resolution beyond the diffraction limit of the imaging system. Upon a successful completion of the proposed project, a low-cost, super-resolution mobile microscope with its resolution exceeding the expensive conventional bench-top laboratory microscopes and a super- resolution bench-top laboratory microscope will be developed to benefit healthcare, environmental monitoring, in addition to the advancement of biology, biochemistry, and medical sciences.